Mechanics of cell growth and division

Project Summary/ Abstract
The cytoplasm is a crowded subcellular environment that is packed with organelles, proteins, nucleic acids
and other large macromolecules, as well as water and small molecules. How cell biological processes
function in this milieu remains poorly understood. Macromolecules present in the cytoplasm are thought to
exert physical forces that contribute to cytoplasmic organization, phase separation, and osmotic pressure.
Cellular density, which is the concentration of cellular components such as proteins and nucleic acids, is a
key predictor of these macromolecular crowding effects. Recent evidence from our lab and others reveals
that density and macromolecular crowding effects are not constant but actually change during the cell cycle,
as well in various physiological and disease states, and during development. However, little is known about
how these changes impact cellular physiology and mechanics. Thus, cellular density and the effects of
macromolecular crowding represent critical but understudied aspects of cellular physiology that likely impact
most cellular processes.
The general goals are to elucidate physical- and molecular- based mechanisms responsible for
cellular processes responsible for cell growth and division: mitosis, microtubule dynamics, nuclear size
control, chromosome mobility and cell wall assembly. A general thrust of the investigations is to determine
how the biophysical properties of the cytoplasm and nucleoplasm impact these diverse cellular processes.
In particular, our studies will address how intracellular osmotic pressures generated by macromolecules act
to dampen microtubule dynamics, inflate the nucleus, modulate the mechanics of the mitotic spindle, and
regulate chromosome motility for DNA repair. Approaches include innovative live cell assays for the
biophysical properties of living cells (e.g. microrheology and quantitative phase imaging) and quantitative
cell biology approaches in the fission yeast Schizosaccharomyces pombe.
These studies will establish a foundation for the emerging field of cellular density and will contribute
to our understanding of a fundamental but understudied aspect of cell biology. This work will significantly
impact our understanding of mechanisms governing cell growth and division that are relevant for biomedical
applications including cancer, aging and fungal pathogenesis.

Public health relevance
Project Narrative Inside the living cell, the cytoplasm is a crowded place occupied by a diverse collection of dynamic molecular constituents. How this environment supports life processes is still not well understood. These studies will show how this crowded environment influences cellular processes such as cytoskeletal and chromosomal dynamics, control of nuclear size control and cell growth.